Cell and Tissue Imaging (CTI)

PROJECT SUMMARY/ABSTRACT (CELL AND TISSUE IMAGING)
The Cell & Tissue Imaging (CTI) Shared Resource (SR), previously called the Morphology Core, was established
as an institutional core at U-M in 1978, approved by the NCI in 1991, and became a University of Michigan
Comprehensive Cancer Center (UMCCC) facility in 1995. The CTI SR is a centralized, shared instrumentation
resource with advanced microscopy and imaging technologies that are vital to studying cell and tissue
morphology and ultrastructure. As such, the facility provides a cost-effective solution for UMCCC researchers to
utilize state-of-the-art imaging instrumentation. In addition to offering instrument time, the CTI SR offers routine
electron microscopy sample processing, sectioning, staining, and analysis. The availability of highly trained
personnel with years of expertise is a distinct advantage to UMCCC members, as is the discount provided by
UMCCC. The facility emphasizes training to ensure that all users operate the advanced equipment properly.